Engineering T Cell Adoptive Therapy for Glioblastoma

PROJECT SUMMARY
This proposal centers on the use of T cell receptor (TCR) directed therapy in preclinical glioblastoma (GBM)
models. GBM remains a difficult cancer to treat, and clinical outcomes remain poor. However, despite the
seismic influence of immunotherapy in cancer, there remain no FDA approved immunotherapies for GBM.
There are several reasons that underlie the difficulty in extending immune-based treatments to the central
nervous system (CNS). GBM harbors few T cells and is considered “non-inflamed”, there is a paucity of
dendritic cells in the brain parenchyma, and a myriad of immunosuppressive features has been identified in
patients. The CNS is also immunologically specialized due to the presence of site-specific elements not seen
elsewhere—e.g., lack of lymph nodes, presence of dural lymphatics, and the blood-brain barrier, among
others. Moreover, the genomic landscape of GBM introduces additional obstacles in that many antigenic and
neoantigenic targets are heterogeneously distributed. Importantly, although heterogeneity is a formidable
challenge to immunotherapy, it is poorly modeled in preclinical settings. Despite these barriers, however, the
final goal of CNS immunotherapy—T cell clonal expansion—remains the same. Here, we will test the use of
adoptively transferred TCR directed T cells to treat preclinical GBM as a gateway to understand key
mechanistic principles for ultimate clinical translation. We have assembled a team with Dr. Charest and Dr.
Petti that brings diverse expertise to this work. The proposed work focuses on a novel transgenic mouse that
targets an endogenous neoantigen, mutant Imp3 (mImp3), in the GL261 mouse model. This mouse, the
Mutant Imp3 Specific TransgenIC (MISTIC) mouse, expresses a TCR that recognizes the H2-Db restricted
mImp3 neoantigen and thus represents an exciting model for TCR-directed cell therapy. In Aim 1, we will
dissect the mechanisms underlying MISTIC therapy and also understand the requirement for endogenous
RAG-dependent lymphocyte populations in effective treatment. Additionally, we will develop and study a new,
autochthonous model of spontaneous, EGFR-driven and neoantigenically-defined GBM model to allow us to
study MISTIC cell therapy in physiologic settings. In Aim 2, we will study the observation that a small subset of
mice escape MISTIC therapy and progress after prolonged survival by interrogating the molecular and cellular
basis of resistance by characterizing changes at both the level of the tumor and microenvironment. In Aim 3,
we will use our isogenic, CRISPR-edited GL261 clones with wild type Imp3 to model heterogeneity and explore
the engineering of MISTIC cells with cytokines and chemokines designed to remodel the GBM
microenvironment as a platform to target heterogeneous tumors. We envision this approach as a proof-of -
concept to use single-antigen systems to unleash epitope spreading. Together, these Aims will reveal new
insights from a TCR cell therapy model that will lead to novel autochthonous model development and explore
engineering approaches for GBM heterogeneity that, together, have immediate translational applications.

Public health relevance
PROJECT NARRATIVE To explore therapeutic platforms for glioblastoma (GBM), we have developed a new transgenic mouse model of T cell receptor (TCR)-directed cell therapy (“MISTIC”) against an endogenous neoantigen in GL261 to explore the efficacy of this treatment approach in established transplantable mouse models and also a novel model of EGFR-driven and neoantigen-defined spontaneous GBM. We will evaluate how to engineer MISTIC T cells to be able to remodel the GBM microenvironment and effectively treat heterogeneous GBM tumors and also explore why some tumors are able to escape adoptive cell therapy. Together, our proposed work will provide new insights into the effective use of directed and engineered TCR cell therapy in GBM that will expand our understanding of immunotherapeutic approaches in the central nervous system and also establish a foundation for immediate clinical translation.